Characterizing a novel hypoxia cell-cycle checkpoint in Cryptococcus

Like many microbes, S. cerevisiae cells will grow in liquid culture until they utilize all the nutrients,
when they cease dividing as unbudded cells in G1 and enter stationary phase. The pathogenic
budding yeast, Cryptococcus neoformans also arrests when cells grow to high density, but the cells
arrest as unbudded G2 cells with fully replicated DNA. This is an unusual arrest point for stationary
phase, and experiments demonstrate the C. neoformans cells arrest in response to low [O2] rather
than depletion of nutrients. Cells reproducibly arrest at the same [O2] levels (approximately 6%)
regardless of the starting conditions. As cells approach the saturation arrest and deplete O2, bud
emergence is inhibited in early S phase and cells don’t bud until G2 phase. This arrest point is
reminiscent of a checkpoint arrest observed in S. cerevisiae cells when budding is inhibited. The
morphogenesis checkpoint prevents unbudded cells from undergoing mitosis and generating
polyploid, multinucleate cells. We hypothesize that in saturated cultures of C. neoformans, low [O2]
inhibits budding and triggers a morphogenesis checkpoint or directly activates a checkpoint that
arrests cells in G2. In response to various intracellular signals, some checkpoints, including the
morphogenesis checkpoint, act to inhibit mitotic cyclin/CDK complexes to prevent entry into mitosis.
Inhibition of these complexes is regulated by the Wee1 kinase that phosphorylates inhibitory residues
on CDK, and the Cdc25 phosphatase which dephosphorylates these sites. The short-term goals of
this proposal are: i) to characterize changes in cell-cycle events during transition from log-phase
growth to saturation arrest to provide clues to what defects might be associated with triggering a
checkpoint arrest; ii) identify changes in the cell-cycle machinery that might impact bud emergence
and checkpoint arrest in G2; iii) evaluate deletion mutants of the C. neoformans orthologs, WEE1 and
CDC25, as well as orthologs of other known checkpoint kinases for their role in the saturation/hypoxia
arrest. These initial studies will set the stage for the long-term goal of identifying the complete
molecular mechanism for the hypoxia checkpoint from the initial molecules that sense low [02] to the
machinery controlling bud emergence and mitotic arrest. As checkpoints normally protect cells from
dividing when cell-cycle events or the genome is perturbed, these studies are key for understanding
how C. neoformans cells proliferate in low oxygen environments. Moreover, understanding the
complete molecular pathways that drive cell-cycle arrest may provide ideas for novel antifungal
strategies that target checkpoint components.

Public health relevance
When Cryptococcus neoformans cells get dense in culture, they stop proliferating due to lack of oxygen rather than lack of nutrients as previously thought. Evidence suggests that low oxygen might trigger a checkpoint pathway that inhibits the cell division machinery. Learning the mechanisms controlling proliferation in response to oxygen is key for understanding how this important human pathogen proliferates in the low oxygen environments encountered during infection.